Common mechanistic biomarkers of vascular and neuro-degeneration

Arterial stiffness, a vascular aging biomarker, has emerged as an important risk factor for
dementia, and is being cross-sectionally linked to brain MRI-measured neurodegeneration and
PET-measured brain Aβ and Tau burden, imaging biomarkers of Alzheimer’s disease (AD) and
AD related dementias (ADRD). However, mechanisms by which arterial stiffness may contribute
to cognitive impairment and dementia are incompletely understood. Recently, several plasma
biomarkers including phosphorylated tau (p-tau) has emerged as promising surrogates for
Aβ/Tau PET burden and neurodegeneration. The goal of this application is to characterize AD
pathology/neurodegeneration connecting arterial stiffness to cognitive impairment using plasma
biomarkers, and identify the diverse and overlapping mechanisms underlying vascular and
neuro-degeneration associated with cognitive impairment through the following aims: A1. To
quantify plasma biomarkers of AD/neurodegeneration, and determine effects of baseline and
progression of arterial stiffness on changes of the plasma biomarkers. A2. To examine effects of
monocyte genomic features (DNA methylomics and transcriptomics) on vascular aging. A3. To
examine effects of monocyte genomic features on changes of the plasma biomarkers of AD/
neurodegeneration. A4. To test effects of SIRT1 on vascular and neuro-degeneration and AD
pathogenesis using in vitro and in vivo AD models. The proposed longitudinal study adding
plasma biomarkers of neurodegeneration to the racially and ethnically diverse MESA cohort with
multi-omics data, carotid vascular and other cardiometabolic measures, brain imaging, cognitive
testing, and clinical MCI/ADRD data across the mid- to late-life transition period, coupled with in
vitro and in vivo experimental studies, has the potential to elucidate the contributions of arterial
stiffness to cognitive impairment and identify molecular and cellular mechanisms that can
explain the common co-occurrence of vascular and early AD/neurodegenerative pathologies
and could serve as targets for disease-modifying interventions.

Public health relevance
Project Narrative The proposed study seeks to identify common mechanisms underlying vascular and neuro-degeneration associated with cognitive impairment and early AD pathogenesis; thus, providing insight into causal molecular processes for disease-modifying interventions.